Tracking and Engaging Disconnected Long-Term Survivors of Childhood Cancer to Improve Adherence to Evidence-Based Screening Guidelines

Project Summary
This application is being submitted in response to the Administrative Supplements on Long-term Cancer
Survivorship. Our proposed project aims to identify and re-engage adult survivors of childhood cancer who
have transitioned from pediatric survivorship care to primary care but are no longer connected to structured
survivorship follow-up. The project leverages and builds on institutional data revealing that over 59% of
transitioned survivors are lost to follow-up at Nebraska Medicine and the Fred & Pamela Buffett Cancer Center
(BCC).The project will use a mixed-methods approach, integrating retrospective EHR data, structured surveys,
and qualitative interviews to understand disengagement patterns, evaluate adherence to Children’s Oncology
Group (COG) Long-Term Follow-Up (LTFU) guidelines, and explore survivor-identified barriers and facilitators
to care. A comparison group of engaged survivors within the adult survivorship clinic will be used to analyze
predictors of continued care adherence. This supplement extends the BCC’s mission to promote innovative
translational cancer research, excellence in cancer education and training, and outstanding patient-centered
cancer care, and to reduce the burden of cancer and cancer health disparities across Nebraska and beyond.
Aim 1: Identify and characterize adult survivors of childhood cancer at BCC who were transitioned to
primary care and are no longer engaged in survivorship care, using electronic health record (EHR)
data. We will use electronic health records (EHR) to identify two groups: (a) survivors who transitioned from
pediatric to adult survivorship care and are currently followed in the adult survivorship clinic (control group, n ≈
60), and (b) survivors who transitioned from pediatric care but are not currently followed in the adult
survivorship clinic (experimental group, n ≈ 90). We will compare demographic, clinical, and geographic
characteristics, with particular attention to rural and underserved populations. Aim 2: Assess adherence to
COG LTFU screening guidelines and unmet needs among disengaged survivors compared to those
retained in adult survivorship care. We will administer structured surveys and conduct chart audits to
evaluate screening adherence, unmet psychosocial needs, and care navigation gaps for survivors in both
groups. Analyses will focus on differences in adherence to recommended surveillance and prevalence of
unmet health and psychosocial needs. Aim 3: Explore barriers/facilitators to long-term survivorship care
not currently followed in the adult survivorship clinic. Qualitative interviews will be conducted with a
purposive sample of survivors from the experimental group (expected n = 20) to identify key barriers to
ongoing engagement in survivorship care to inform future re-engagement efforts. Findings will inform the
design of future re-engagement strategies.

Public health relevance
Project Narrative This project will identify and re-engage adult survivors of childhood cancer who have transitioned from pediatric survivorship care to primary care but are no longer connected to structured follow-up. Using a mixed-methods design, we will integrate EHR data, structured surveys, and survivor interviews to examine patterns and predictors of disengagement, adherence to Children’s Oncology Group (COG) Long-Term Follow-Up (LTFU) guidelines, and survivor-identified barriers to care. Findings will inform survivor-centered strategies to promote re-engagement and improve adherence to risk-based care.